Exploring the mechanism by which defects in the PIX signaling pathway result in cardiomyopathy

Project Summary
Integrin adhesion complexes (IACs) play a critical role in cardiomyocyte attachment to the extracellular matrix
and in force transduction—both essential processes required for effective blood pumping. Mutations in several
genes encoding IAC proteins are associated with cardiomyopathies, conditions with 50% lethality rate within five
years of diagnosis. Notably, nearly half of known cardiomyopathy cases lack an identifiable genetic mutation,
underscoring an urgent need to discover additional genes linked to the disease. To address this gap, we
translated our findings from C. elegans to a mammalian model by generating a cardiomyocyte-specific knockout
of β-PIX (β-PIX-cKO) in mice. In C. elegans, we identified PIX-1 (the β-PIX ortholog) as a guanine nucleotide
exchange factor that regulates IAC assembly in muscle cells. β-PIX-cKO mice develop dilated cardiomyopathy
by 8-months of age and exhibit premature lethality between 9- and 11-months. Additionally, I localized β-PIX to
three key cardiomyocyte structures where IACs are present: costameres, intercalated disks, and Z-disks. Our
research aims to identify the specific small GTPase and GAP involved in the PIX pathway in mouse
cardiomyocytes. To this end, we will establish an overexpression model of two candidate GAP proteins, allowing
us to conduct parallel studies with β-PIX-cKO mice. Using these murine models, we will examine how PIX
pathway disruptions affect IAC protein localization, expression levels, and the functional adhesion strength of
cardiomyocytes. These experiments will shed light on the mechanisms by which β-PIX deficiency leads to
cardiomyopathy. Furthermore, our findings could support the inclusion of PIX pathway genes in genetic screens
for cardiomyopathy, potentially enabling earlier diagnosis and more targeted treatments. While mutations in
several IAC proteins are linked to cardiomyopathy, the mechanisms driving disease onset remain largely
unknown; our model system may also offer broader insights into cardiomyopathy that develops from mutations
in many other proteins.

Public health relevance
Narrative Heart muscle cells rely on protein anchors to attach to their surroundings and effectively transmit the force from each heartbeat. When these anchors are not properly assembled, it can lead to heart diseases like cardiomyopathy, a major contributor to heart failure. We discovered a molecule that controls anchor formation, and when this molecule is missing in mouse hearts, cardiomyopathy develops, suggesting that a lack of this molecule leads to cardiomyopathy in humans.